Implementation and effectiveness of a multi-sectoral promotores de salud intervention in rural Oregon's summer meal program to promote health quality of life among Latine families

7. Project Summary
Food insecurity, exposure to ethnic and language discrimination, and lack of access to educational information
are common and intersecting social determinants of health (SDOH) that are multi-level (affecting the individual,
household, and community) and are precursors to multiple health conditions (e.g., premature mortality, heart
disease, type 2 diabetes, hypertension, mental health disorders). Because of the multifinality of their risks (i.e.,
exposure to a single SDOH can result in multiple adverse health outcomes), it is essential to implement
preventive interventions that directly intervene on SDOH at a system level to disrupt the pathways from SDOH
to broad health quality-of-life outcomes. These SDOH and health disparities have been replicated in
Hispanic/Latine communities and are even worse among Latine families in rural areas. Further, Latine
individuals represent an increasing proportion of the U.S. population under age 40, and thus children and their
caregivers are a group who could greatly benefit from primary prevention approaches that disrupt SDOH
earlier in the lifespan, when biological and social underpinnings of health outcomes are still quite malleable. To
address this known health disparity, we propose a bi-phasic research project that builds upon and adapts our
Oregon Saludable: Juntos Podemos (OSJP) collaboration with community-based organizations in the health
sector to expand the health benefits of the Oregon Department of Education’s summer meal program for Latine
families in rural settings in Oregon. We propose a Type 2 hybrid implementation-effectiveness study that uses
a dual randomized controlled trial design at 96 summer meal sites nested within 24 school districts. The dual
RCT design includes a simultaneous test of the implementation strategy (culturally responsive health worker
outreach to Latine families to encourage attendance at the summer meal program) and the OSJP-Familias
intervention (on-site brief, psychoeducation combined with resources/support for enrolling in additional year-
around services), making a novel contribution to the field. We have six aims that include three Phase 1 Aims
tied to measurable transition milestones: (a) collaborative planning with our community advisory board, our
health and education partners, and the Multi-Sectoral Preventive Interventions (MSPI) research network, (b)
scientific planning to collaboratively adapt our efficacious OSJP outreach and implementation frameworks,
implementation strategies, and intervention into OSJP-Familias, and (c) operational planning that includes
creating protocols and manuals of procedure for all study elements. Our three Phase 2 Aims include: (a)
testing our primary implementation hypothesis, that a greater proportion of Latine children will be served at
summer meal program sites in the active outreach implementation condition, (b) testing our primary
intervention hypothesis, that OSJP-Familias would be associated with improved health quality-of-life in children
and caregivers, and (c) conducting a cost-effectiveness analysis of the health quality-of-life gains relative to
implementation costs of OSJP-Familias. Secondary hypotheses test mediators, moderators, and sustainability.

Public health relevance
8. Project Narrative Access to healthy food and psychoeducational health interventions that support child and caregiver health are needed for Latine communities because they experience a disproportionate share of damaging social determinants of health (SDOH), including food insecurity, exposure to discrimination, and inadequate access to education information. The proposed project seeks to improve Latine children’s access to healthy food through Oregon Saludable: Juntos Podemos-Familias (OSJP-Familias), by partnering with the Oregon Department of Education’s summer meal program and augmenting it with culturally and linguistically relevant outreach and a brief on-site psychoeducational intervention for Latine caregivers that would be delivered by partners in the health sector. We expect that OSJP-Familias will result in greater numbers of Latine children served by the summer meal program and improved health quality-of-life in Latine caregivers and their children, which has implications for creating sustainable system change to prevent poor health outcomes across generations.